Developmental Research Project Program

RI-INBRE Developmental Research Project Program (DRPP) Project Summary
The overarching goal of the Rhode Island IDeA-Network of Biomedical Research Excellence (RI-INBRE) program
is to improve institutional capacity for biomedical research excellence and student experiential training in the State
of Rhode Island. The primary function of the RI-INBRE Developmental Research Project Program (DRPP) is to
design and oversee a diversity of competitive funding mechanisms designed to meet the varying research needs
and career stages of participating investigators at all nine RI-INBRE network institutions. This includes two
research-intensive institutions, six Primarily Undergraduate Institutions (PUIs) and one community college. The
RI-INBRE Research Project mechanisms include Early Career Development awards for early-career investigators
at URI/Brown and the PUIs and Collaborative Research awards for early-career faculty at the PUIs who
collaborate with an established URI/Brown investigator. The DRPP also solicits and evaluates applications for the
training-intensive Summer Undergraduate Research Fellowship awards for PUI investigators. In the renewal
period, the DRPP will continue to adjust its funding structures and activities to better support the developmental
research pathways for students, postdoctoral fellows, and early-stage investigators. We will create pilot awards
to provide seed funding for very early-stage investigators. In addition, we will create proposal development pilot
awards to support investigators collecting preliminary data for extramural proposals. These mechanisms will
complement the existing DRPP awards by providing additional defined steps on the developmental scaffold. This
will help early career investigators to move toward independence and competitiveness for research grants. We
will expand our pool of external mentoring consultants to provide early-career investigators with independent
expert advice. Expanding research training opportunities for underrepresented students and postdoctoral fellows
will produce a diverse pool of trainees ready to fill biomedical positions in Rhode Island. Taken together, these
new DRPP initiatives will improve the training environment for multiple levels of the biomedical research
workforce, which will help build biomedical capacity and retain talent in Rhode Island.